STUDY OF THE LONG TERM EFFECTS OF THE HEMATOPOIETIC STEM CELL TRANSPLANTATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Bone marrow transplant recipients who receive total body irradiation have difficulty with neuropsycological function, growth,endocrine function and secondary malignancies. To determine if transplantation without total body irradiation but with busulfan, has less side effects, we will longitudinally evaluate patients who receive busulfan to those who receive total body irradiation for therapy related side effects.